Community Engagement Plans of the Resource for Native MS Guided Structural Biology

We propose a Resource for Native Mass Spectrometry Guided Structural Biology. The Resource will build,
validate, and disseminate integrated workflows for structural characterization of protein:protein, membrane
protein:lipid, and protein:RNA complexes that are critical for an array of cellular and organismal processes. The
broad mission of the Resource is to empower biomedical researchers to use native MS workflows to define m/z,
stoichiometry, heterogeneity, connectivity, topology, conformational diversity, and relative subunit binding
strengths of protein complexes with high sensitivity and throughput. This information will guide selective
integration of higher resolution structural biology tools. The overall goal of the Community Engagement Core of
the Resource is to ensure the broadest possible access to optimized native MS instrumentation and workflows
by fostering the active engagement of the national research community. We will do this by sharing workflows
and technology in addition to fostering commercialization of the technologies developed in the Resource. In order
to achieve this the resource will enlist and actively support Collaboration and Service projects that will benefit
from the expertise and mature technologies available in the Resource at any given time. We have already
identified 22 such projects, and as these projects develop we will actively seek new collaboration and service
projects, working with the biomedical research community to make existing and emerging native MS
technologies readily accessible and broadly available. In addition, the resource will improve understanding of
native MS guided structural biology within the research community by training biomedical researchers to apply
these novel methods to their own research questions. We will take a number of approaches in order to achieve
this goal, including regular meetings with the Collaborate & Service and Driving Biomedical Projects teams, an
annual short course at the American Society of Mass Spectrometry conference, an annual short course at the
Resource, as well as hands-on training activities, and informative documents and videos on data analysis. The
Resource will promote technology dissemination and commercialization of the developed resources to put
cutting-edge native MS guided structural biology technologies and methods into the hands of biomedical
researchers. In order to ensure rapid, sustainable dissemination, of the developed technologies, we will draw
upon on our industrial and third party vendor collaborations to provide early adopters with pre-commercial
products for use in their labs. We will start with a small number of beta testers and progress towards full
commercial product offerings by multiple major instrument manufacturers, proposing instruments with different
performance characteristics and different price ranges. Alongside the dissemination approaches detailed above,
we will pursue traditional approaches, including publishing in peer reviewed journals and presenting the work at
conferences, meetings, and symposia.